Improved estimation of pollen exposure, mixtures, and risk of respiratory illness

PROJECT SUMMARY
Through this predoctoral fellowship focused pollen, air pollution, and respiratory health, I will obtain in-depth
training in exposure assessment and health effect estimation, biostatistical methods for environmental
mixtures, science communication, and teaching and mentorship. Pollen-related illnesses affect 60 million
Americans, with direct medical expenses estimated in the billions of dollars annually. Trends suggest that the
prevalence of pollen-induced asthma and allergic rhinitis is on the rise, which is expected to increase health
disparities and the already-substantial health costs associated with these conditions. There is emerging
evidence that pollen is an under-appreciated environmental justice issue that adds to the disproportionate
environmental burdens faced by people from racial and ethnic minority groups or lower income groups.
Nevertheless, pollen is an understudied environmental risk factor with scarce evidence on several important
questions related to pollen-health associations. The project proposed here fills significant gaps in our
understanding through the following specific aims: 1) Implement a multi-location time-series study of pollen and
respiratory morbidity that includes assessment of individual- and area-level indicators of social vulnerability; 2)
investigate how pollen and air pollution may interact to influence the risk of respiratory morbidity; and 3)
develop a city-wide automated pollen monitoring network in that emphasizes community-level data production
to improve exposure estimates and quantify potential exposure disparities. I hypothesize that individual- and
area-level disparities in pollen-associated risk of respiratory illness exist (Aim 1) and may be exacerbated by
the synergistic effects of pollen and air pollution (Aim 2) as well as heterogeneous local pollen exposures (Aim
3). The proposed research will yield insight into pollen-related risk disparities across populations in 23 U.S.
locations, potential synergistic effects of pollen and air pollution via implementation of environmental mixtures
methods, and potential within-city exposure disparities via community-level pollen exposure monitoring. By
investigating the unequal burden of pollen-associated respiratory illnesses and improving how we monitor and
assess pollen exposure, this research has the potential to guide public health recommendations and improve
health outcomes for millions of people. The proposed work complements the NIH Climate Change and Health
Initiative Strategic Framework and connects directly to several NIH special interest areas on climate change
and health (NOT-ES-22-006; NOT-HD-23-006).

Public health relevance
PROJECT NARRATIVE Pollen-related illnesses affect 60 million Americans and emerging evidence suggests pollen may contribute to respiratory health disparities. This research aims to understand individual and area-level factors driving pollen- related health disparities across the US, investigate the synergistic effects of pollen and air pollution, and discover potential differences in pollen exposures across Atlanta communities through the use of automated pollen sensors. Results from this work will guide clinical recommendations and targeted interventions aimed at reducing health disparities and improving health outcomes for millions of people.